GENDER AND RACIAL DIFFERENCES IN ETHANOL BIOAVAILABILITY

We plan to measure the oral and intravenous alcohol bioavailability simultaneously using deuterated intravenous ethanol and unlabelled oral ethanol in Caucasian and Asian men and women.